RISKS AND OUTCOMES OF ENHANCED CONSENT IN SYMPTOM-PROVOCATION RESEARCH

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The overall objective of the study is develop pilot data for several studies related to the psychobiology and neurobiology of trauma, including the resubmission of an R01 grant application in response to PA-07-277, Research On Ethical Issues In Human Subjects Research in which reviewers called for more preliminary data pertaining to protocol development. The aim is to develop preliminary data for the resubmission and for future related grant submissions.